Administrative

The Administrative Core is responsible for the managerial oversight of the P01. This includes all administrative and budgetary matters, scheduling advisory committee meetings as well as regular meetings of all project investigators. This Core will also work to assure that the direction and focus is periodically examined with an eye towards clinical relevance and implementation. Reflecting the PIs interest in training the next generation of scientists in areas related to radiopharmaceutical therapy (RPT), this core will encourage and facilitate internships, summer student engagement, and other opportunities to expose students (at all levels) to the work performed in the cores and projects. Specifically, this core will Aim 1: Provide overall scientific leadership and managerial oversight of the P01, including integration of research activities across the projects and cores. Aim 2: Encourage scientific rigor and maintain focus on clinical relevance. Aim 3: Encourage student engagement. Through these functions, the Administrative Core will provide an essential service to each of the Research Projects and Cores to help accomplish the proposed goals and objectives of the P01. The longer-term administrative objective of this core and the overall program PI is to foster interactions and collaborations that will endure beyond the P01 period and lead to breakthroughs in basic, translational, and clinical research in imaging, dosimetry, and radiobiology of α-particle emitter radiopharmaceutical therapy.

Public health relevance
Narrative The Administrative Core will help assure that the program project is well-managed financially. This core will assure facilitate scientific review and ongoing administrative support and coordination of the program as a whole.